Development of TransKinect: A Clinically Robust System for Transfer Assessment

Improper transfer technique predisposes wheelchair users to developing upper arm pain and injuries. A
large body of research on the proper ways to transfer to avoid extraneous forces exists but these techniques
have not been well disseminated into clinics. In a recent study we found that up to 63% of Veterans who use
wheelchairs have many transfer skill deficits including improper arm positioning, use of handgrips, and head-
hips relationship. We propose to develop TransKinect, an automated transfer assessment system for clinical
settings that can help therapists and their patients to identify improper transfer motions and provide guidance
on how to improve their technique. The system will be based on the Transfer Assessment Instrument (TAI)
which is a valid and reliable scale used to assess the quality of transfer technique but requires new therapists
considerable time to learn and to make judgements on appropriate body positioning and mechanics.
TransKinect will eliminate the need for background knowledge and training on the TAI and provide objective
measurement of body and joint motions using a portable, low-cost markerless motion capture sensor. In prior
work, we developed machine learning classifiers for TransKinect that can differentiate proper from improper
techniques with an average accuracy of 94% using the sensor data recorded during a transfer. These classifiers
will be embedded in system software designed to `watch' a transfer, automatically compute the TAI score,
present the results in real-time and provide education and training recommendations to therapists and their
patients.
The specific aims are: 1) to iteratively develop the TransKinect software platform involving input from an
expert panel, 2) to validate TransKinect for clinical use by comparing the TAI scores generated by the system
against those of expert therapists 3) to test the usability of TransKinect with a novice group of therapists and 4)
field test the system in a VA clinical setting to examine its utility, usability and effectiveness. TransKinect will be
iteratively refined using the data that is collected in each aim of the study.
For Aim 1, a prototype of TransKinect will be developed and tested with field experts familiar with the
TAI. For Aim 2 three of the expert therapists and TransKinect will score the TAI after watching 30 Veterans
perform wheelchair transfers. We aim to achieve at least 80% of agreement between the two sets of scores
and will refine the software using data collected in this aim if necessary. For Aim 3, 10 novice therapists wlll
use TransKinect to assess a model patient and provide their feedback on the usability and perceived
usefulness of the system. We hypothesize that the therapists will find TransKinect easy to setup and use and
that it increases their awareness and understanding about transfer technique. In Aim 4 the TransKinect system
will be introduced into clinical practice at the Clement J. Zablocki VA Medical Center where we will track the
system's utility, usability and effectiveness. Effectiveness will be evaluated by comparing TAI scores on patients
who were assessed at an initial and followup visit to the clinic. We hope to show that the system can be
successfully integrated into standard practice and is sensitive to detecting improvements in transfer technique.

Public health relevance
Veterans who use wheelchairs and independently transfer often develop upper limb pain and injury from overuse. Research has shown that pain and injuries can be lessened if certain techniques are used during transfers. The goal of this project is to develop and test an interactive therapy tool called TransKinect that can be used to evaluate the body mechanics of a patient's transfer and point out the specific areas where the patient needs improvement. It will also provide education on how to improve in those areas. Teaching and providing training in transfer techniques may enable patients to experience greater mobility, autonomy and freedom to participate in the home and community, and vastly improve quality of life. The proposed study will collect important data on the feasibility of integrating the TransKinect into the healthcare arena. If successful, the TransKinect could become an effective and affordable clinical tool to help wheelchair users learn safe transfer skills, reducing the potential for transfer related pain and injuries.